Allogenic Viral Specific Engineered T Cell for treatment of PML

Project Summary/Abstract:
The goal of this application is to train Dr. Sasha Gupta, a physician scientist, with the skills necessary to become
an independently funded investigator studying cellular therapeutics for the treatment of autoimmune and
infectious neurologic conditions. In this research proposal, she proposes to identify, isolate and sequence
clonally restricted T cell receptors from patients with diverse genetic backgrounds that are highly specific for JC
virus VP1 antigens and have anti-viral activity in vitro and in vivo. These findings can advance the development
of anti-JC virus T cell therapies that could revolutionize the treatment of progressive multifocal
leukoencephalopathy. This research is accompanied by a career development and training plan that will build
on Dr. Gupta’s clinical training in neuroimmunology and her postdoctoral training in in vivo testing of experimental
cellular therapies. Her training will focus on 1) virology, 2) immunology, 3) bioinformatics, and 4) clinical
implementation of cellular therapies. This career development and training plan will include a combination of
formal coursework; mentored practical training; conference, meeting, and workshop attendance; and guidance
from an exceptional team of mentors and advisors/collaborators. Altogether, this award will help prepare Dr.
Gupta for an independent research career focused on developing cellular therapies for treatment of autoimmune
and infectious neurologic conditions.

Public health relevance
Project Narrative: Progressive multifocal leukoencephalopathy (PML) is a devastating brain infection caused by JC virus (JCV) in immunocompromised individuals for which there are currently no effective antiviral therapies. The aims of this study are to identify and isolate JCV specific T cell receptors (TCRs) from diverse class I HLA healthy donors and to validate the ability of T cells expressing these TCRs to clear JCV infection. The ultimate goal is to develop a therapy that is based on the dominant class I HLA backgrounds in the general population, in order to develop safer and more effective PML therapy.